COMPARISON OF MIDODRINE AND PLACEBO IN PATIENTS WITH SEVERE HYPOTENSION

To evaluate the efficacy of midodrine compared to placebo for inhibition of the symptoms of syncope due to orthostatic hypotension due to autonomic dysfunction.